Single Cell Analysis Facility

Over the past year, SCAF has supported over 110 projects from more than 40 NCI Center for Cancer Research laboratories which involved the sequencing of roughly 3.3 million single cells. This work included studies to understand mechanism and potential limitations of immunotherapy and cellular therapeutics in pre-clinical cell culture and mouse models, as well as from samples of patients enrolled in clinical trials. Collaborative support from SCAF also enabled a better understand the composition of cell types and cell phenotypes within the tumor microenvironment and peripheral blood in multiple disease states by utilizing single cell sequencing to examine heterogeneity within tissue samples. Utilizing high throughput CRISPR-enabled functional genomic screens, insight was gained as to how individual or sets of target genes affect transcriptional phenotypes in model cell lines to help better understand their role in normal development and their dysregulation in disease. Members of the SCAF team also promoted better understanding of available technologies and how they can be utilized through individual consultations, hosting and presenting seminars, and support for relevant scientific interest groups at NIH.